Genes underlying reproductive behavior physiology and neuronal development

Project Summary/Abstract
To understand mental health and disease, we need to understand the function of the brain at the level of genes,
gene regulatory networks, neurons, circuit structure, and physiology. Drosophila has emerged as one of the
most powerful model systems for these questions, given the range of tools and the tractability of analyzing
complex behaviors at all these levels. This proposal seeks to understand Drosophila reproductive behaviors.
One reason Drosophila is such a powerful system is that the sex-specific master regulatory transcription factors
that direct reproductive behaviors are known. This has provided a powerful molecular inroad into identifying and
manipulating the neurons that underlie these behaviors. These tools can also be used to perform neuron-specific
mutational studies to discover the functions of genes that direct behaviors, which leverages one of the biggest
strengths of the Drosophila model system. In addition, this system affords an unparalleled model to both examine
the sex-specific development of these neurons and how they are modified by adult experiences. Research using
the Drosophila model has continued to uncover biologically important processes that have informed on human
health and disease, including studies of the nervous system and behavior. The work will build off of my
laboratories 15-year NIGMS funded research program. We will continue to address these behavioral questions
using cutting-edge molecular-genetic, genomic, proteomic, behavioral and microscopy tools to gain insights into
complex behaviors.

Public health relevance
Project Narrative Understanding human mental health disorders requires a basic understanding of the nervous system. It is critical to understand how neuronal connections are built during development and how neural circuits function in the adult. This study seeks to understand at a molecular-genetic level how the potential for behavior is built into the nervous system. These studies will proceed with analyses in a multi-cellular organism, so we can interrogate the role of genes, proteins and neural circuits in a functionally relevant context to gain insight in how a circuit for a complex behavior is built and functions.